High-Resolution Breast MRI at 3.0T

Project Abstract
Overview: Ductal carcinoma in situ (DCIS) comprises approximately 20% of breast cancers diagnosed annually
in the US. DCIS is currently treated aggressively with surgery and radiation, or mastectomy. Yet the excellent
long-term outcome for many DCIS patients indicates that there is substantial over-treatment of DCIS, and trials
of active surveillance are starting.
Relevance: The critical question is which cases of DCIS can be safely followed without being removed? One
major unmet need is that 1/4 of DCIS cases diagnosed by core needle biopsy actually harbor occult invasive
cancers that merit deﬁnitive treatment. Accurate identiﬁcation of DCIS cases to exclude these invasive cancers
has been identiﬁed as one of the major roadblocks to active surveillance. Currently, MRI is viewed as the
most promising staging strategy. However, while MRI is twice as sensitive as mammography for breast cancer
detection overall, it is not that accurate for selectively detecting invasive cancers in a background of DCIS.
Approach: Over two prior funding cycles, we have made key developments in high spatiotemporal resolu-
tion breast MRI that are industry standards, with numerous advances in other breast MRI sequences including
diffusion-weighted imaging (DWI). Here, we propose to investigate and test two promising areas of MRI technol-
ogy to improve discrimination of invasive cancer from DCIS. In Aim 1, we will develop dynamic contrast enhanced
MRI with high spatiotemporal resolution sampling, spatiotemporally-sparse compressed-sensing reconstruction,
integrated fat-water separation and non-rigid motion correction. We will also incorporate novel pharmacokinetic
mapping that includes modeling of arterial bolus dispersion for better lesion discrimination. In Aim 2, we will
develop diffusion-weighted MRI with multi-shot methods that use novel shot-to-shot motion correction, fast-spin-
echo diffusion imaging for better performance around biopsy markers, and steady-state diffusion for 3D imaging.
Finally in Aim 3, we will validate and test the accuracy of these new techniques in large patient studies, to show
their beneﬁt for invasive tumor detection in DCIS patients compared to conventional ACR-standard breast MRI.
Summary: The advanced MRI techniques that we propose to develop, validate and test in this proposal have
tremendous potential to identify which DCIS patients can safely select active surveillance and which need deﬁni-
tive treatment. High accuracy for invasive cancer will provide this value with many fewer false-positive biopsies
than conventional breast MRI.

Public health relevance
Project Narrative Every year, 50,000 American women undergo breast surgery for non-invasive breast cancer, also known as ductal carcinoma in situ (DCIS). Active surveillance (AS) has been proposed as a non-surgical management strategy for DCIS because 46-87% of the time DCIS does not progress to clinically relevant illness. We propose to develop and validate new high-resolution multi-contrast magnetic resonance imaging (MRI) technology that can accurately discriminate which patients with DCIS harbor occult invasive cancer, and therefore are not suit- able for AS, from patients without invasive cancer who are suitable for AS, to reduce over-treatment of breast cancer.